2023 Malaria GRC & GRS

Summary/Abstract
The combination of the first approved malaria vaccine, the COVID-19 pandemic and a flattening -- since 2015 -
- of malaria morbidity and mortality rates has created an opportunity to reflect and re-imagine.
What do we need to do to rein in a parasite that has felled armies, shaped the human genome and continues to
evolve to elude new medications? Which new approaches, or more nuanced versions of old approaches, will
stymie the insect vector, Anopheles mosquitoes? Can we double down on transmission, both to and from the
human host? Ninety percent of the burden of malaria falls on sub-Saharan Africa: what critical capacities are
needed there to prevent infection and better manage disease?
At the 2023 Malaria Gordon Research Conference (GRC, 28 May – 5 June 2023, Rey Don Jaime Grand Hotel,
Caselldefels, Spain), we will gather as a community to learn from a broad array of speakers representing
traditional areas of malaria interest and expertise (clinical medicine, entomology, epidemiology, parasitology,
vaccines, immunology) and to cross-fertilize with contributions from historians, neuroscientists, communication
and implementation experts, neurologists and data scientists.
The GRC will be held immediately following a Malaria Gordon Research Seminar (GRS), which targets
students, postdoctoral fellows and junior investigators, and in the tradition of Gordon Conferences, both will
provide safe and inclusive environments for these younger members of the malaria community to discuss new,
unpublished data with established investigators and thought leaders during formal sessions, in front of posters,
over coffee, at meals, and whilst recreating outdoors.
The meeting will prioritize the participation of investigators from malaria-endemic areas. By including
individuals from all career stages and a variety of disciplines, we hope to foster innovation and support new
collaborative relationships to capitalize on this pivotal moment in malaria control and eradication.

Public health relevance
Project Narrative Although recent progress toward decreasing the global burden of malaria has slowed and even reversed in some regions, the pace of discovery in clinical and translational malaria research is accelerating, and promises to improve patient outcomes, decrease the malaria burden in populations, and accelerate malaria elimination efforts.